Structural basis of dynamin-mediated membrane fission actin bundling and interaction with binding partners.

Project Summary/Abstract
Dynamin GTPases have critical roles in mediating endocytosis by wrapping around the neck of budding vesicles
to catalyze membrane fission necessary for the release of nascent vesicles from the plasma membrane.
Recently, we discovered a novel role for dynamin in bundling numerous actin filaments, which has implications
for actin-mediated processes, such as cell-cell fusion and migration. While structural and biophysical studies
have elucidated the mechanism of dynamin assembly and constriction of membranes, several unanswered
questions remain including how dynamin is actually organized and mediates fission within cells, how dynamin
forms the final pre-fission state where it wraps around lipid tubules in a superconstricted state, how dynamin
binds substrates via the proline rich domain (PRD), and how substrate binding regulates dynamin activity. The
long-term objective of this application is to elucidate the mechanism of dynamin-mediated membrane fission
from in vitro and in vivo studies, and to define the mechanism of dynamin interaction with actin and SH3 domain-
containing proteins that recruit dynamin to sites of endocytosis. These objectives will be addressed by the
following specific aims: (1) determine the atomic model of dynamin in the superconstricted prefission state
and define the structure of the PRD; (2) investigate the assembly of the dynamin helical polymer on membranes
within cells; and (3) Elucidate the mechanism of PRD interaction with actin filaments and SH3 domain-containing
binding partners. The rationale for these aims is that: (1) there is no atomic model describing the structural
basis by which dynamin constricts membranes to 3.4 nm in the superconstricted state where spontaneous
hemifission and membrane fission occurs; (2) how dynamin is actually organized in cells has not been reported;
and (3) the structure of the critical PRD and how it binds dynamin substrates including actin, amphiphysin and
intersectin is unknown. The research design and methods are as follows : Aim 1, Apply cryo-electron
microscopy (cryo-EM) to determine the structure of full-length dynamin (containing the PRD) organized around
lipid tubules in the superconstricted state; Aim 2, obtain cryo-electron tomograms and subtomogram averages
of dynamin within cells transfected with a GTPase-deficient dynamin mutant which delays membrane fission and
extends the lifetime of dynamin helices on cellular membranes; Aim 3, obtain the cryo-EM structure of actin
filaments decorated with PRD from dynamin, as well as complexes of dynamin/amphiphysin and
dynamin/intersectin. This work is of

Public health relevance
Project Narrative This project investigates the mechanism by which dynamin enables membrane fission during endocytosis, how SH3 domain-containing proteins interact and regulate dynamin during endocytosis, and how dynamin interacts with actin filaments during various cell processes that rely on the actin cytoskeleton. This work is of public health relevance because dynamin has critical roles in endocytosis necessary for cell signaling, and for cell-cell fusion and migration which require actin bundling by dynamin. Furthermore, dysregulation of dynamin causes neuropathies, cancer and defects in organism development.